Effectiveness and implementation of a health system intervention to improve quality of cancer care for rural, underserved patients

PROJECT SUMMARY
There is growing evidence that limited access to high-quality cancer treatment is one of the main drivers of
higher cancer mortality rates among rural cancer patients. Our analyses of Iowa Cancer Registry data indicate
that 40% of rural patients with breast and colorectal cancers receive most or all definitive treatment in rural
hospitals that do not collect or monitor data on their quality of cancer care, and are not accredited by the
American College of Surgeons Commission on Cancer (CoC). Our data also shows these patients are less
likely to receive guideline-concordant care. Given patients' needs and preferences to receive cancer care
locally, a promising strategy to improve quality of cancer care and outcomes in rural populations is to intervene
directly with the community hospitals in these areas. New evidence has demonstrated effectiveness of this
approach: the Markey Cancer Center Affiliate Network (MCCAN) was formed by the University of Kentucky
(UK) Markey Cancer Center to improve quality of cancer care in their own rural, low-resourced state, one that
leads the nation in cancer incidence and mortality. Over the last decade MCCAN has facilitated the sharing
and diffusion of resources and best practices throughout their network. As a result, affiliates markedly
improved performance on established, cancer care quality measures and expanded their services (e.g.,
psychosocial and survivorship support). They were also almost 3 times more likely to obtain CoC accreditation
than their matched controls. However, the MCCAN model has not been rigorously defined, evaluated or tested
in any other setting. We propose to adapt this successful health system-level intervention for Iowa, establishing
the Iowa Cancer Affiliate Network (I-CAN). Although there are similarities between Iowa and Kentucky's
populations that suggest the MCCAN model may be a good fit, there are also significant differences in
healthcare infrastructure and resources that require careful adaptation of the intervention prior to its
implementation in order to retain its effectiveness. We will use novel, rigorously developed, theory-based
implementation science methods to identify MCCAN's core functions (i.e., what makes it effective), study the
implementation process and evaluate how I-CAN performs in a new context. We have identified 4 rural, Iowa
hospitals to participate in this intervention trial and developed expert support teams to assist key stakeholder
groups within each hospital. Through interviews and qualitative analyses, we will assess determinants and
outcomes of the implementation process, and perceived value of the CoC accreditation standards and the
intervention itself as a way to improve the quality of cancer care for their patients. We will compare compliance
with treatment-related quality measures and the proportion of CoC standards of cancer care implemented in
target and control hospitals, pre- and post-intervention using a difference-in-difference estimator. This work
could lead to dissemination of similar models across rural settings thereby improving quality of care, reducing
rural disparities in cancer outcomes and giving rural hospitals an avenue to demonstrate their quality of care.

Public health relevance
PROJECT NARRATIVE The 60 million rural residents of the United States have a lower rate of new cases of cancer per year compared to urban residents but have a higher rate of cancer deaths per year, partly due to the greater difficulty in accessing high-quality cancer treatment in rural areas. As rural patients are less likely to receive care in urban cancer centers with cancer specialists who treat very large numbers of cancer patients, an effective strategy used by the University of Kentucky Markey Cancer Center has been to share their expertise and resources with smaller community hospitals across Kentucky to help improve their quality of care. We propose to study the Kentucky model in order to identify and characterize its core functions (i.e., what made it effective in improving quality of care in community hospitals), adapt it to a new rural setting, and determine its value to the hospitals and impact on cancer care.